PHASE I, DOSE-ESCALATING STUDY OF SU5416 IN PATIENTS

The primary objective is to assess the maximum tolerated dose ("MTD") and toxicities of SU5416 administered twice weekly via intravenous injection for four weeks, with two-week follow-up.